Molecular Mechanisms Underlying Adaptor-Mediated Integrin Signaling in a Species-Specific Manner

Project Summary
This is a request for an NIGMS Administrative Supplement to NIGMS grant R35GM119560, to purchase a J-
1100 Circular Dichroism (CD) Spectropolarimeter. Our previous structural and functional studies allow us to
design peptidomimetic inhibitors targeting integrin-related diseases such as thrombotic disorders, cardiovascular
diseases, and many autoimmune diseases. Our data suggest the helicity of the peptidomimetics is required for
its inhibitory function. Access to the J-1100 CD Spectropolarimeter will provide the necessary capabilities to
maximize productivity and fully achieve the aims of the proposed research project. Institutional matching funds
will contribute to the purchase of this instrument.

Public health relevance
Project Narrative Abnormal expression and hyperactivity of integrins lead to severe diseases including cardiovascular diseases, impaired inflammatory responses, and enhanced tumor metastases. Our recent progress on understanding regulatory mechanisms underlying integrin activation inspires us to design and characterize peptidomimetics that inhibit integrin activation. Since the helicity of the peptidomimetics is required for its inhibitory function, we request funds to obtain the JASCO J-1100 Circular Dichroism Spectropolarimeter that will ensure our research capacity.